PHENYLKETONURIA &OTHER DISEASES CAUSED BY DEFECTS IN BIOPTERIN-DEPENDENT ENZYMES

Increased tetrahydrobiopterin biosynthesis accompanies immune system stimulation. Tetrahydrobiopterin regulates proliferation of erythrocyte precursor cells.